National Health and Nutrition Examination Survey 2011-2012 and 2013-2014 Physical

To provide additional support for the Physical Activity (PA)/Sleep and Strength components in NHANES. The PA/Sleep component will involve providing an accelerometer-based monitor to survey participants ages 6+ years and request that the monitor be worn around the clock on the wrist for seven days. The device will collect movement data to provide information about PA as well as the duration and efficiency of sleep. For the Strength component, participants ages 12+ years wil b easekd to squeeze a hand-grip dynamometer with each hand and the strength of the squeeze will be recorded.